Molecular Underpinnings in the Establishment of an Oncogenic 3D Genome inResponse to Environmental Arsenic Exposure

Abstract
Establishing the influence of pollutants on genome function is essential in defining their impact on human
health. Environmental pollutants such as inorganic arsenic (iAs) are responsible for over thirteen million deaths
yearly. Importantly, 24% of the diseases caused by environmental exposures might have been avoided by
disease prevention, diagnosis and the development of safer metal-based therapeutic agents. In order to
understand how these pollutants cause disease, we need to understand how pollutants change gene
expression. Proper gene regulation is essential for normal growth, development and etiology of diseases such
as cancer. Eukaryotic DNA stored as chromatin plays an integral role in gene regulation. At the one-
dimensional (1D) level, chromatin is found as nucleosomes and at the three dimensional level (3D), chromatin
is found in loops and topological domains, both of which regulate gene expression by allowing accessibility to
the DNA wrapped up as chromatin. Inorganic arsenic is a ubiquitous metal that impacts gene regulation
through modulating the epigenome. We recently provided the epigenetic landscape (DNA methylation, histone
PTMs and histone variants) mediated by iAs. This landscape though important, makes it difficult to decipher
whether the observed effects on gene activity are due to local changes in epigenetic environments, or effects
caused by remote changes several kilobases away, such as the activity of enhancer(s). Additionally, the effect
of the 3D chromatin structure supersedes that at the 1D chromatin level. This 3D information is mediated by
CTCF, known as a ‘master weaver’ of the genome, and any dysregulation of the CTCF binding alters this 3D
structure, resulting in gene dysregulation. We recently showed that iAs selectively inhibits CTCF from binding
to some of its target sites and instigating oncogenic expression patterns. Interestingly, carcinogenesis is not a
linear process but involves a several hybrid in-between stages till final cancer state. We therefore hypothesize
that by inhibiting CTCF binding, iAs reorganizes the genome to maintain specific topologically-activated
domains at the 3D chromatin structure to drive specific oncogenic potentials. To test this hypothesis, we will
map CTCF binding (Aim 1), chromatin 3D (Aim 2) and ChIP-seq of histone marks (Aim 3) as cells undergo iAs-
mediated carcinogenesis. The knowledge derived from the proposed studies will allow us to characterize the
resulting gene regulatory network mediated by iAs exposure, and allow us to unambiguously anchor iAs
exposure to changes in the CTCF interactome in the process of iAs-mediated cancer. Additionally, these
studies will allow us to decipher how iAs initiates, establishes and maintains particular chromatin signatures
that ultimately drive gene expression in iAs pathogenesis. Such studies are critically needed for the
identification of translational targets and the development of therapeutic drugs needed in iAs-disease
pathology.

Public health relevance
The proper regulation of gene expression is essential for the development and health of all organisms. Our work advances the study of how DNA, found as chromatin, plays an integral part in gene regulation (transcription initiation and gene splicing. This knowledge will help guide the development of diagnostic and therapeutic tools, e.g., built upon knowledge of alternative splicing.